FDACS - AFRPS Maintenance with Mutual Reliance Initiatives

Project Summary
Overall
Florida Department of Agriculture and Consumer Services (FDACS)
Maintenance AFRPS w/ Mutual Reliance Initiatives
PAR-25-003
Division of Agricultural Environmental Services (AES)
Proposal to FDA for Participation in AFRPS Maintenance with Mutual Reliance
Initiatives
Project Date: August 1, 2025 – July 31, 2028
The Florida Department of Agriculture and Consumer Services (FDACS) is requesting
funding under PAR-25-003 to support maintenance of the Animal Food Regulatory
Program Standards (AFRPS) and enhance mutual reliance between the FDACS Feed
Regulatory Program (program) and the U.S. Food and Drug Administration (FDA). This
request includes participation in AFRPS Maintenance and Mutual Reliance Initiatives
tracks specified below.
This project is designed to maintain and continuously improve the program’s
implementation of the AFRPS. The program's primary objective is to contribute to a
national, integrated food safety system by developing consistency in regulatory
processes and assuring the quality of inspection and enforcement activities. This will be
achieved through the periodic evaluation and updating of the program's regulatory
foundation, training protocols, risk-based inspection procedures, and enforcement
strategies. The program will continue to enhance its capabilities through ongoing self-
assessments, effective data management, and the use of modern technology.
Consistent adherence to these standards is essential for ensuring the validity and
defensibility of regulatory actions, thereby protecting public health and promoting
industry compliance. The initiative will increase the program’s capacity to effectively
regulate animal food safety through standardized procedures, enhanced inspection
capabilities, and collaborative enforcement strategies.
FDACS Feed Regulatory Program will build upon its existing infrastructure and
regulatory expertise to meet project objectives, with measurable outcomes in areas
such as inspection efficiency, compliance rates, and standards integration.

Public health relevance
Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.